Neural Mechanisms for Perceiving Object Motion During Self-Motion

? DESCRIPTION (provided by applicant): Perceiving the motion of objects in our environment is critical to many aspects of daily life. Although much is known about the neural basis of visual motion perception, almost all of that knowledge is derived from experiments in which the observer's eyes, head, and body remain stationary. When an observer moves through the environment, the motion of an object on the retina depends on both the movement of the object in the world and the self-motion of the observer. Thus, to estimate the motion of objects in the world, self-motion must be factored into the computations. This capability is critical to daily activities such as driving a vehicle, during which it is important to accurately judge the movement of other objects in the environment, such as other vehicles or pedestrians. As perception of self-motion is known to be degraded in neurological disorders such as Alzheimer's disease and during normal aging, understanding the neural basis of object motion perception during self-motion is of substantial importance to developing therapies for these deficits. We propose a series of experiments that provides the first systematic exploration of the neural mechanisms of object motion perception during self- motion. Aim #1 explores visual mechanisms by which optic flow may be parsed into components related to self-motion and object motion. Behavioral studies have demonstrated perceptual consequences of flow parsing, but the neural basis is unknown. We test the hypothesis that responses of neurons in retinotopic motion areas mediate the perceptual effects of flow parsing Aim #2 employs a novel behavioral paradigm in which macaques are trained to judge object motion during self-motion, and to report their percepts in either world-centered or head-centered coordinates. We hypothesize that both visual and vestibular self-motion signals make important contributions to perception of object motion. By recording from neurons in multiple brain areas during performance of this task, we seek to identify neural correlates of the computations that are used to flexibly represent object motion in either world-centered or head- centered coordinates. The proposed research is directly relevant to the research priorities of the Strabismus, Amplyopia, and Visual Processing program at the National Eye Institute.

Public health relevance
PUBLIC HEALTH RELEVANCE: We propose a series of experiments to unravel the neural basis of perception of object motion during self-motion. Deficits in perceiving self-motion are among the earliest consequences of Alzheimer's disease, and associated deficiencies in judging object motion may substantially impact patients' lives (such as when driving a vehicle). Little is known about how the brain computes object motion during self-motion, and the knowledge gained will inform treatment of disease and development of visual prosthetics in active observers.